NURTURE: Northwestern University Recruitment to Transform UnderRepresentation and achieve Equity

Contact PD/PI: SIMON, MELISSA A.
Project Summary/Abstract

Public health relevance
Contact PD/PI: SIMON, MELISSA A. Project Narrative